Synaptic to circuit homeostasis in the Drosophila locomotor system

What sets the transmission strength of synapses? What determines their plasticity properties? How do
synapses homeostatically adjust synaptic weight to accommodate to changing conditions and ensure robust
behavior? What happens if synaptic homeostasis is insufficient to compensate for a disruption or a change in
demand, are other backup mechnisms of compensation recruited and, if so, how do they work? We combine in
vivo super-resolution quantal imaging of synaptic transmission and behavioral analysis with focused RNAi
knockdown in one cell type and single cell transcriptome analysis to address these questions. Our preparation
is the Drosophila larval neuromuscular junction—an ideal system for imaging and genetics, which shares
synaptic signaling machinery and functional properties with vertebrate central excitatory synapses. Our in vivo
quantal analysis has revealed that two converging glutamatergic motor neuron (MN) inputs have great
heterogeneity in evoked release probability (Pr) and short-term plasticity and that only Ib undergoes “synaptic
homeostasis,” whereby transmitter release changes to compensate for altered postsynaptic sensitivity. Our
goal is to identify the molecules responsible for the synapse to synapse and input to input differences. Equally
exciting, preliminary work suggests the existence of a novel layer of gain control: “circuit homeostasis,” which
is recruited when synaptic transmission is so compromised that “synaptic homeostasis” cannot compensate
sufficiently. The circuit homeostasis system adjusts neural firing pattern in the presynaptic cell and upstream
circuit to preserve locomotor behavior when synaptic transmission is inadequate. Our goal is to define the
mechanisms that assure neural output by setting and adjusting transmitter release and firing dynamics.
Progress will provide fundamental insight into the robustness of the nervous system that preserves health and
which may cause disease when it goes awry.

Public health relevance
We propose to employ a new method that we have developed of in vivo super-resolution quantal imaging of synaptic transmission and behavioral analysis with cell-specific protein expression disruption and single cell transcriptome analysis to study the homeostatic mechanisms that make the nervous system robust to disruption. Our goal is to define the molecular mechanisms that assure neural output and preserve behavior by setting and adjusting transmitter release and firing dynamics. Progress will provide fundamental insight into the robustness of the nervous system that preserves health and which may cause disease when it goes awry.